Probiotic neuroimmune modulation of morphine tolerance

The vast majority of adults in the US have taken an opioid drug for pain relief. Oral opioids have revolutionized
our ability to treat post-surgical pain and, thereby, drastically shortened post-surgical hospital stays. However,
recently there has been an unprecedented increase in the number of patients taking oral opioids for pain who
have developed an opioid use disorder (OUD). In fact, more than 280 people per day died of an opioid overdose
in 2021(1). While the dramatic increase in OUD has coincided with the much-reported increase in opioid
prescriptions, it is still true that only a fraction of patients who are prescribed opioids for pain develop an OUD.
If we could identify those pain patients most at risk prior to opioid treatment, we could potentially stem the tide
of opioid abuse and overdose death. Recent studies have shown that alterations in the gut microbiome can
influence a plethora of central nervous systems disorders, leading to widespread acceptance of the concept of
a gut-microbiome-brain axis(2, 3) . It is compelling that, coincident with the increase in opioid prescriptions, there
has also been a large increase in the routine and often unnecessary use of oral antibiotics—a trend that that has
altered the gut microbiome of an entire generation. Not surprisingly, given the widespread expression of opioid
receptors in the gut, opioids have been shown to alter the gut microbiome. Furthermore, alterations in the
microbiome have been shown to alter opioid analgesia and reward, suggesting that opioids influence the gut-
brain axis(4-8). However, to date, no studies have examined whether the gut microbiome influences the
development of OUDs. In our preliminary studies, we capitalized on both behavioral variability in a mouse model
of antinociceptive tolerance and OUD, and mouse microbiome variability, both innate and in response to
morphine, to identify microbial biomarkers of OUD. One such biomarker we identified is Akkermansia muciniphila
(AKK), a key gut commensal of mammals that promotes gut homeostasis and has emerged as an important
biological intervention in diseases with diverse etiologies. Specifically, we found a significantly higher abundance
of Akkermansia muciniphila (AKK) in mice that did not develop antinociceptive tolerance to morphine during
voluntary chronic oral morphine use. This discovery led to our central hypothesis, to be tested here, that AKK
protects against the development of OUDs. Here we will interrogate the molecular mechanisms by which AKK
protects against OUD (Aim 1) and assess how AKK supplementation impacts dynamics of microbiome
community interactions and final composition in a morphine-exposed gut (Aim 2). Together these studies could
inform development of immediate and non-invasive therapeutic strategies to extend the analgesic efficacy of
opioids for chronic pain conditions while reducing the development of OUD.

Public health relevance
Chronic opioid use produces analgesic tolerance and opioid use disorder (OUD) in only a subset of both humans and mice. Identifying and validating the biomarkers that predict liability for OUD could improve therapeutic utility and reduce risk.